Center for Latino Health Research Opportunities-CLaRO - Community Engagement & Dissemination Core

Revised Abstract Section

Project Summary/Abstract
Latino populations in the US continue to experience health disparities, particularly in substance abuse,
violence/trauma, HIV/AIDS, and mental health (SAVA+MH). For underserved Latinos in Miami-Dade County
(MDC), poverty and lack of access to health care have adversely impacted health outcomes, exacerbating
SAVA+MH health disparities in these communities. MDC is the most populous county in Florida, and it is home
to 2.7 million residents, of which 71% are Latino, making it the largest metropolitan area in the US with a Latino
majority. New research efforts and strategies are needed to ameliorate health disparities affecting the large
population of underserved Latinos in South Florida; a well-trained, and diverse, multidisciplinary health
disparities workforce is needed to address this critical public health issue. Thus, the proposed CLaRO
Community Engagement and Dissemination Core (CEDc) aims to integrate community stakeholders in the
collaborative training of early-stage investigators (ESI) to address Latino SAVA+MH health disparities using
equitable implementation science strategies. These efforts aim to produce (a) innovative, community-engaged
research to reduce Latino health disparities, and (b) new community-engaged strategies to facilitate translation
of findings into community settings. The CEDc and its Community/ Scientific Advisory Board (CSAB) will
collaborate with CLaRO’s Investigator Development Core (IDc), and leverage support from our network of
community stakeholders, to train ESI at the University of Miami (UM) and Florida International University (FIU).
CEDc activities will help these ESI develop plans for implementation of evidence-based interventions and other
research in a collaborative manner that engages the community; CEDc training efforts will include collaborating
to develop strategies to facilitate dissemination of Pilot Project findings into target communities. The following
CEDc Specific Aims will be accomplished through the mutually beneficial and long-standing collaboration
between FIU and the UM as CLaRO. Aim 1: To convene the CLaRO CSAB to serve as an advisory board to
CLaRO’s Pilot Project Program and mentor CLaRO Pilot Awardees. The CSAB will collaborate and guide Pilot
Awardees on existing factors that may act as barriers or facilitators in accelerating uptake and implementation
of evidence-based interventions (EBIs) that address SAVA+MH health disparities among vulnerable Latino
subgroups. Aim 2: To leverage the CLaRO CSAB to facilitate community engagement among (a) CLaRO Pilot
Awardees and other trainees and (b) community stakeholders that serve local Latino communities. Aim 3. To
facilitate an effective, equitable, and collaborative dissemination plan for CLaRO Pilot Projects that (a) engages
community members, partnering organizations, service providers, and other stakeholders in sharing and
translating Pilot Project findings with the community, and (b) assist Pilot Awardees in creating culturally tailored
SAVA+MH dissemination strategies in collaboration with target communities.